Training Program in Lung Biology and Disease

DESCRIPTION (provided by applicant): This is a new application to fund Pulmonary research training at the University of Texas Southwestern Medical Center, at the postdoctoral (MD, PhD) level. The proposal is born out of a collaborative effort between the Pediatric and Adult divisions involved in lung research at this Institute, and is thus interdepartmental at its core. Twenty six funded, experienced investigators representing 12 different clinical and basic science departments and centers form a solid, diverse training force, organized into four thematic tracks: 1) Pulmonary vascular disease; 2) Interstitial lung diseases; 3) Lung epithelial cell and differentiation disorders; and 4) Immunity/Inflammation/Sepsis. Trainees will be paired with one of our mentors and enter one of these four tracks. Besides mentor-based teaching, trainees will receive a comprehensive track- and project-specific didactic curriculum. Both clinical and basic science trainees will be guided by an individualized advisory committee that has both basic and clinical science mentors, to broaden the trainee's perspective and facilitate bench to bedside thinking. Emphasis will be placed on maintenance of project focus, creative experimental design, state of the art technology, and careful early career guidance. The strength of this program lies in the highly collaborative Institutional environment, the unique interdepartmental leadership and training faculty of the program, and the experienced and dedicated faculty serving as trainers.